Administrative Supplement for Quality Assurance/Quality Control

PROJECT ABSTRACT/SUMMARY As a CTSA hub, the Wake Forest Clinical and Translational Science Institute (CTSI), we are committed to producing high quality, accurate documentation for our programs and services to support our CTSA programs and services. In an effort to maintain consistency, efficiency, and increase the quality of CTSA-related information to NCATS, we are requesting support for an individual to perform quality reviews of CTSA-related submissions to NCATS. This would include submissions to the newly developed eRA Human Subjects System, the XTrain and eRA Commons systems to ensure correct and appropriate documentation required for all projects and efficient management of the overall process. As such, we request funding support for a full time (12 cal. mos.) Quality Assurance Associate Project Manager position to support all facets of our reporting activity.

Public health relevance
PROJECT NARRATIVE The Wake Forest Clinical and Translational Science Institute (CTSI) is an organizational entity designed to implement high quality programs and services offering tailored training tools, and broadly disseminate improved methods and processes to increase the efficiency, safety, and reproducibility of preclinical and clinical science. We are committed to training the next generation of scientists and leaders and the CTSI will partner with our community and CTSA hubs to ensure high quality reporting, establishing standards across the administrative functions, and working with investigators utilizing our services and programs to ensure compliance, efficacy and safety in carrying out projects utilizing CTSI resources.